"Core D" Clinical Sample and Tumorigenesis Core

CORE D SUMMARY
The unifying goal of this program project is to define the biological function of noncoding RNAs in
gammaherpesvirus AIDS malignancies. Though in vitro experimentation remains a core component of scientific
advancements, approaches using clinical samples and in vivo systems are absolutely essential for interrogating
normal biological processes, defining critical determinants of pathology, and developing rational strategies to
combat disease. The purpose of Core D (Clinical Sample and Tumorigenesis core) is to provide essential
services for Projects 1, 2 and 3 that include clinical sample acquisition and storage (Aim 1); histological
processing, clinical pathology scoring, RNAscope in situ hybridization, and GeoMx digital spatial profiling of
clinical tumor samples (Aim 2); and in vivo experimentation using humanized mouse, xenograft mouse, and
murine virus tumorigenesis systems (Aim 3). Thus, Core D will aid in the overall goal of the program by utilizing
modern in vivo techniques and tumorigenesis models to define the biological relevance of virus and host
noncoding RNAs identified in Projects 1, 2 and 3.

Public health relevance
CORE D NARRATIVE The purpose of Core D (Clinical Sample and Tumorigenesis core) is to provide essential services for Projects 1, 2 and 3 that include clinical sample acquisition and storage (Aim 1), histological processing and diagnostics (Aim 2), and in vivo experimentation using humanized mouse, xenograft mouse, and murine virus tumorigenesis systems (Aim 3). Thus, Core D will aid in the overall goal of the program by utilizing modern in vivo techniques and tumorigenesis models to define the biological relevance of virus and host noncoding RNAs identified in Projects 1, 2 and 3.